Protocol Review and Monitoring System

PROJECT SUMMARY/ABSTRACT – PROTOCOL REVIEW AND MONITORING SYSTEM
The PRMS at FCCC involves a two-stage review process. The first stage is done by the disease site team (DST)
and the Office of Clinical Research Feasibility Committee (OCF). DSTs assess studies using two levels of
criteria. They will decline protocols if there is lack of resources (e.g. patient population, clinical research
personnel), or competing trials (1st level criteria). We have enhanced the process for first stage review by
development of a redcap form for capturing declined studies. Protocols found to be of interest are formally
reviewed at disease group meetings that occur at least monthly, assessing scientific interest, significance to
patient population and catchment area (2nd level criteria). The DSTs are using a new uniform tool to assess
treatment studies that considers data on annual accrual potential, potential to accrue minority and
underrepresented patients, competing studies, source of the trial (i.e. IST/NCTN versus industry) and
consideration of the phase/potential impact of the study question; these data are calculated to give the PRMS
score, a percent of the highest possible score with studies rated as Good (<50%), Excellent (51-75%) or
Outstanding (>75%). Once proposed for the second stage review, the OCF evaluates protocols to determine if
trials are able to be conducted. Upon approval by OCF, studies enter Second Stage review done by the Research
Review Committee (RRC) which evaluates and provides scientific prioritization of all interventional trials at
FCCC, with careful deliberation on investigator initiated studies. The RRC is comprised of physicians from all
disciplines, translational researchers, pharmacists, biostatisticians, as well as researchers from nursing and the
Cancer Prevention and Control Program. We have enhanced the review regarding relevance to the catchment
area by adding a new review criterion; we also have developed a training program for community members to
serve as RRC reviewers with the first cohort to begin in Q1 2024. All new protocols that contain human research
at FCCC are reviewed prior to submission to the Cancer Center's Institutional Review Board.
The PRMS also includes the RRC Protocol Accrual Monitoring subcommittee (PAMS), which is responsible for
monitoring the progress of studies to ensure that the use of ongoing OCR resources in support of studies is
justified. The subcommittee meets bi-weekly to review accruals and communicate with investigators when
protocols are at risk for termination due to poor accrual or recommended for closure due to low accrual. We have
enhanced our oversight by assessing new studies at 6 months; those with no accrual are given a 6-month
warning letter.